Novel primer for bonding and debonding of high-strength dental ceramics

SUMMARY
We aim to combine the laser energy with a novel primer for bonding reversibly to high-strength ceramic crowns.
This proposal seeks to investigate the novel primer’s bonding and debonding capabilities to address the
destructive and traumatic removal of high-strength all-ceramic crowns using high-speed rotary instrumentation
which in addition compromises the underneath tissue, and fatigues the patient and clinician. This common clinical
problem, affecting many dentists and their patients, is highlighted by the National Dental Practice-Based
Research Network, with an estimated 2.5M all-ceramic restorations removed yearly. We introduce a novel,
drill-free, efficient, and non-yet-available debonding approach for high-strength ceramic restorations.
This method uses a unique binding promoter system comprising carbon nanosphere chains (CNSCs)
and 10-methacryloxydecyl dihydrogen phosphate (MDP), facilitating strong bonding to ceramics but
also enabling debonding after laser irradiation. This method offers innovative bond-debond applications
for primers in dentistry for high-strength adhesively bonded ceramics such as lithium disilicate glass-ceramic
and partially stabilized zirconia (PSZ) ceramics. We will utilize an erbium-based laser, widely adopted in dental
practice, especially in North America, with a dominant 35% market share in 2021. The proposal’s specific aims
are 1) Characterize the bonding and debonding capabilities of lithium disilicate and PSZ ceramics treated
with the novel CNSC-MDP-based primer against benchmark products, and 2) Evaluate spiral and s-
shaped laser irradiation modes to promote efficient debonding. In addition, we will verify thermal changes
across different ceramic thicknesses, color changes, contact angle, viscosity, and the biocompatibility of the
novel primer. Our initial findings indicate a paradigm shift regarding PSZ ceramics’s low thermal
conductivity, as laser irradiation using 7.5 W at 20 PPS effectively transmits heat through PSZ ceramics,
softening the resin cement without affecting its integrity. Another novel aspect is the rigorous thermal mapping
of the laser irradiation and testing of standard geometry and clinically relevant specimens. We will test up to five
CNSC concentrations (0.06, 0.12, 0.18, 0.24, and 0.30 wt%). The findings of this proposal will elicit the dual
functionality of the novel primer for convenient, efficient, and predictable debonding of resin-bonded all-
ceramic crowns. Anticipated outcomes include improved removal ease, reduced patient trauma, and
restoration preservation, yielding significant time and cost savings. This revised application mantains the
original focus and incorporates reviewer's feedback, including bonding to tooth structure, verifying ceramics’
optical properties, and measuring CNSCs concentrations’ viscosity. This R03 will serve as a stepping stone for
future studies into primer activation using various external photonic triggers, such as varied laser energies and
potential UV irradiation. Future research will expand to other ceramic restorations, multi-unit, and 3D-printed
prostheses to streamline the novel primer across various applications and transition it from lab to clinic.

Public health relevance
NARRATIVE Tooth-shaped caps made from durable and aesthetically pleasing ceramic materials, require replacement when they or the tooth underneath are damaged and can’t be restored. The strong adhesive used to keep the cap in place makes removal with a drill uncomfortable for patients. We propose a drill-free method using a new compound that easily unglues the ceramic cap when activated by heat. 1